The Role of Experience in the Production and Perception of Phonological Sequences

DESCRIPTION (provided by applicant): This project continues our investigation of the production and perception of phonological sequences. The project's guiding assumption is that the phonological processing system is constantly changing. It adapts to recent experience, while continuing to reflect the accumulated experience of a lifetime of speaking and listening. The proposed research seeks to understand the adaptability of the phonological processing system, with an emphasis on the malleability of the system's use of general phonological patterns, such as phonotactic constraints. It is well known that speech errors or slips of the tongue exhibit the phonotactic regularity effect: Errors rarely create combinations of sounds that are illegal in the language being spoken. For example, an English speaker might mispronounce "nun" as "nung", but not "ngung" because that violates the constraint of English that "ng" can never begin a syllable. We created a laboratory analog to this effect and used it to demonstrate learning. Experimental subjects recited strings of syllables in which consonants were artificially restricted to particular positions in syllables;for example, /f/ always occurred as a syllable onset. As subjects experienced these syllables, their slips became strongly sensitive to the distributions of the consonants. For example, nearly every misplacement of /f/ obeyed the rule that /f/ is an onset for this experiment. These data suggest that subjects implicitly learned the sound distributions, and this learning affected their productions. We demonstrated the same effect in perception. Subjects listened to syllables with consonant-position restrictions;in a later speeded repetition task, new syllables that were consistent with the phonotactics of the experiment were repeated more rapidly than syllables that were inconsistent. The proposed research uses these techniques to investigate learning mechanisms in the phonological processing system. The studies manipulate the phonological patterns to be acquired and make direct comparisons between production and perception and between learning by adults and infants. These experiments are informed by psychological theories of learning and linguistic theories of representation, and the obtained data will be used to constrain development of computational models of implicit learning in the phonological processing system. The research will yield a new understanding of how the processing system responds to experience, which ultimately will contribute to the treatment of language disorders and to language pedagogy. PUBLIC HEALTH RELEVANCE The project studies how implicit learning, that is, learning by doing, shapes the way that we perceive and produce speech. As such, the proposed research will contribute to the understanding and, ultimately, the remediation of developmental and acquired speech, language, and reading pathologies. Therapies for language pathology often assume that learning is taking place, but current methods are not based on precise theories of learning mechanisms. Consequently, an analysis of such mechanisms in a specific domain -- here, phonotactic learning -- has the potential to make a notable contribution to the development of therapeutic interventions. If we discover how the speech processing systems of infants, older children, and adults change naturally with experience, we can use this knowledge to engineer changes that can benefit individuals of all ages who suffer from linguistic and reading disorders.